Center for Improving Care Delivery for the Aging (CICADA)

Project Summary – Research Education Component
The Research Education Component (REC) of the proposed renewal of Penn’s Center for Improving Care
Delivery for the Aging (CICADA) builds upon the major contributions and lessons learned from the CICADA
program’s initial funding period and is responsive to recent dynamic changes in society, aging, health care, and
research methods. Using an equity-first approach, the renewal is designed to strengthen the training and
mentoring of CICADA’s current RCMAR Scientists and expands the program’s outreach to form career-long
relationships with CICADA Alumni. In this renewal, the CICADA REC will provide mentoring and training in
equity-integrated health services research (HSR) focused on aging to RCMAR Scientists from minoritized and
underrepresented backgrounds, with the goal of strengthening diversity, equity, inclusion, and accessibility
(DEIA) in the field. We target three categories of trainees to become RCMAR Scientists: (1) MD or MD/PhD
clinical fellows who have completed their residency, (2) PhD postdoctoral trainees, and (3) MD/PhD, MD, or
PhD junior faculty, defined as Instructor or early-stage Assistant Professor (<3 years in the role). To help build
our pipeline of promising researchers, we will continue to engage in targeted efforts to identify undergraduate
and graduate students from minoritized and underrepresented groups to participate in mentored research
experiences.
In keeping with our first funded cycle, the CICADA REC will select three new RCMAR Scientists each year
through a competitive call for pilot applications. Each RCMAR Scientist will conduct a 1-year pilot research
project with funding and high-quality, intensive mentoring and training provided by CICDADA REC and
established Penn and Penn-affiliated health services researchers and mentors, focusing on aging and equity-
integrated HSR. CICADA mentors have experience in guiding and nurturing developing investigators,
particularly those from minoritized and underrepresented groups. Once the RCMAR Scientists have completed
their 1-year pilot project, they will remain a part of the CICADA community as CICADA Alumni and continue to
benefit from CICADA's research training, mentoring, sponsorship, and support, as they develop into successful
independent researchers in equity-integrated HSR for aging populations, mentors, and eventual leaders in
academia. To meet its goals, the REC has the following Specific Aims (1) To identify, recruit, and select
CICADA's RCMAR Scientists and support them in conducting 1-year pilot research projects focused on priority
HSR and aging areas of inquiry; (2) To provide CICADA's RCMAR Scientists with structured training and
mentorship to become independent equity-integrated health services researchers in aging, using an equity-first
approach; (3) To foster longstanding relationships with, and continued career development for, CICADA’s
current and former RCMAR Scientists.